Administrative Core

Administrative Core Project Summary/Abstract
The ND INBRE has been highly successful in meeting the 4 central goals expected from all INBRE
programs as detailed in the Request for Applications. The overall goal of the administrative core is to
continue and enhance the success of the ND INBRE program. The leadership of the administrative core
will continue the success in priming the pipeline of the next generation of research and health
professionals through the promotion of undergraduate research. The new funding cycle will start our
quest to go from our current support of over 1,000 undergraduates in research to our new goal of 2,000
students. New additions to the internal advisory committee (IAC) will add strength to our goal of
providing diversity, equity and inclusion of under-served in ND. The administrative core is expanding its
promotion of STEM activities in the middle and high schools through a community-based partnership
with the North Dakota Science Teachers Association. The program will add each year to the 3,000
students already supported by the ND INBRE to compete in the Science and Engineering Fairs. The
administrative core will continue to provide multiple forums for students and faculty to interact and
network with their peers. Two of these forms are focused on American Indian research and health
disparities, one on the campus of Cankdeska Cikana Community College. The administrative core,
through its interactions with the IAC, will continue to enhance research infrastructure that increases the
research base and capacity. The ND INBRE’s participation in the CTR Dakota Cancer Collaborative on
Translational Activity and on the SHARP Hub represents over 30 million dollars in extramural activity.
The highly successful evaluation of the program, especially as it applies to student career outcomes, will
remain a central focus of the administrative core. Few programs, other than ours, have successfully
tracked the career outcomes of a high percentage of their undergraduate researchers.